Airborne PCBs and Their Metabolites: Risk Factors for Adverse Neurodevelopmental Outcomes in Adolescence

PROJECT SUMMARY: PROJECT 1 – PCB NEUROTOXICITY IN ADOLESCENTS
Previous work by the Iowa Superfund Research Program demonstrated that indoor air, especially in U.S. schools,
is contaminated with polychlorinated biphenyls (PCBs). Such exposure represents a current public health concern
for U.S. adolescents considering recent data indicating PCBs interfere with neurodevelopment. In addition,
findings from Project 1 have implicated astrocytes as a target for PCBs with a putative mechanism involving
mitochondrial dysfunction. Despite such evidence, there is a gap in scientific knowledge regarding the mechanism
of neurotoxicity via which airborne PCBs, such as the School and Superfund Air Mixture (SSAM), target the
developing brain, and in addition, the role of SSAM metabolites compared to the parent compound. Therefore, a
critical need exists to establish how SSAM PCBs affect neurotoxic outcomes in adolescents and elucidate
mechanisms by which human metabolites of these PCBs cause neurotoxicity. The long-term goal of this project
is to assess and prevent neurotoxicity outcomes following exposure to PCB congener profiles detected in the air
of U.S. schools and at PCB-contaminated Superfund sites. Our central hypothesis is that adolescent exposure to
airborne PCBs, and their metabolites formed in vivo, is mechanistically linked to altered neurodevelopmental
outcomes through oxidative stress and mitochondrial dysfunction in astrocytes. We propose that SSAM PCBs,
and especially their metabolites, target mitochondrial astrocytes and cause disruption of neighboring cells,
including microglia and neurons, yielding neuroinflammation and cell injury, respectively. This hypothesis is based
on strong preliminary studies showing that metabolites of SSAM PCBs: a) are present in the rodent brain; b)
cause oxidative stress in vitro and in vivo; c) target astrocyte mitochondria causing a change in form/structure and
rapid disruption of bioenergetics. Guided by these preliminary data, the novel hypothesis will be tested by: 1)
determining the effects of an inhaled PCB mixture on biochemical markers and behavioral outcomes indicative
of neurotoxicity in mice (collaboration with Project 2); 2) characterizing the role of astrocytes and interactions
with other cell types in PCB-mediated neurotoxicity in cells in culture; and in addition: 2.1) identifying
mechanistic targets of PCBs in primary mouse astrocyte cultures in vitro; and 2.2) assessing the contribution of
astrocyte interactions with other cell types (microglia and neurons) from mice on the adverse outcomes of
PCBs in vitro. The proposed research is conceptually and technically innovative as it seeks to elucidate a
mechanism of airborne PCB neurotoxicity stemming from mitochondrial dysfunction in astrocytes via PCB
metabolites and utilizes novel cell culture methods. The outcomes of these studies will pinpoint novel
mechanisms by which PCBs elicit neurotoxic responses. Completing this research will impact public health by
providing fundamental, mechanistic insights needed to advance the human risk assessment of exposure to PCBs
to inform strategies to prevent or mitigate adverse outcomes following PCB inhalation.

Public health relevance
PROJECT NARRATIVE: PROJECT 1 – PCB NEUROTOXICITY IN ADOLESCENTS Project 1 of the Iowa Superfund Research Program will assess how exposure to airborne PCBs and their metabolites during adolescence, a critical period for brain maturation, is mechanistically linked to altered neurodevelopmental outcomes through oxidative stress and mitochondrial dysfunction. This outcome is relevant to public health because it will inform future risk assessment for neurotoxicity resulting from exposure to airborne PCBs and their metabolites. Therefore, the proposed research is pertinent to the goals of the Superfund Research Program to protect human health from the impact of hazardous Superfund chemicals, such as PCBs.